Epigenomic Regulation in Pancreatic Cell Growth

This proposal requests the renewal of our major source of long-standing funding for investigating transcription,
chromatin, and epigenetics in pathophysiological mechanisms underlying pancreatic diseases. Our studies will
directly extend our knowledge on common diseases, such as chronic pancreatitis and pancreatic ductal
adenocarcinoma (PDAC), both painful and incurable disorders of the exocrine pancreas for which effective
prevention protocols and treatments remain to be fully developed. Our OVERALL OBJECTIVE is to
investigate how epigenomic regulators work as nuclear effectors of common mutations associated with human
pancreatic diseases. Although we believe that our concepts and methodologies can be applied to any
“mutation-epigenetic-disease triad”, we will focus on understanding histone-based pathways as effectors of
KRAS in established genetically-engineered mouse and human patient-derived models of pancreatic diseases.
Notably, while similar to genetic alterations epigenetic changes are inheritable, they can be reversible by
pharmacological treatment. Our PRELIMINARY DATA report the discovery of a key role for the Histone H3
Lysine 9 (H3K9) methylation pathway and its associated methyltransferase, EHMT2, as an epigenetic regulator
of oncogenic KRAS. EHMT2 together with its paralog EHMT1 are the main histone lysine methyltransferases
responsible for catalyzing histone H3K9 dimethylation. However, no information is known regarding the
function of EHMT1 and EHMT2, either separately or as a complex, in relationship to pancreas physiology or
pancreatic diseases. We will test a combined, mechanistic and translational CENTRAL HYPOTHESIS, namely
that the EHMT1/EHMT2 complex works as an epigenetic effector of KRAS during ADM and PanIN formation
as well as their progression by pancreatitis. Our SPECIFIC AIMS are: 1. To determine mechanisms by which
inactivation of the EHMT1/2 complex antagonizes KRASG12D-mediated ADM and PanIN formation alone and in
pancreatitis; 2. To evaluate biochemical mechanisms by which KRAS signaling in pancreatic cells regulates
the enzymatic activity of the EHMT1/2 complex; and 3. To discover epigenetic mechanisms by which the
EHMT1/2 complex mediates the effects of KRAS. We will use an extensive battery of cellular, molecular and
whole organism experiments, executed in a highly collaborative environment with state-of-the-art techniques.
By focusing on better understanding epigenomic pathways that serve as effectors downstream of common
mutations in the pancreas, our design seeks to maximize the yield of rapidly translatable mechanistic
knowledge. Discoveries from this proposal will have a valuable positive impact because the application of
concepts, techniques, and drugs from the field of epigenomics is anticipated to provide new opportunities for
the management of patients affected by pancreatic diseases, thereby bearing significant biomedical relevance.

Public health relevance
Public Health Relevance This proposal is significant to public health as it examines new mechanisms by which genetic mutation and epigenetic, or "above genetic", events cooperate to regulate cell growth underlying two major diseases of the exocrine pancreas, pancreatitis and pancreatic cancer, which are a substantial health burden in the USA with high mortality rates. These efforts to understand the key ways that these diseases seize pathways to control harmful gene expression will help build the rationale for the development and evaluation of new approaches for better patient therapies. Furthermore, the proposed investigations are directly relevant to NIDDK's commitment to conduct and support medical research on digestive diseases to improve people's health and quality of life.